Mini-gantry for proton therapy

ABSTRACT
We hypothesize that a room-temperature, 360°, isocentric proton therapy gantry fits inside a
Linac vault, a.k.a the Mini-Gantry. This would enable the conversion of two neighboring Linac
vaults (one for the Mini-Gantry and one for the accelerator) into an ultra-compact proton therapy
center and increase the accessibility of proton therapy, especially in urban centers with existing
linear accelerator vaults where space is a constraint. Existing proton therapy gantries are larger
than 24’ in diameter. The proton gantries at Massachusetts General Hospital occupy 3 stories.
The IBA ProteusOne gantry is 25’ in diameter. None of these fit in a typical 12’ high basement
of a high-rise building and require custom-designed spaces. The aim is to optimize the proton
maximum energy and treatment field size in the Mini-Gantry while maintaining 12’ diameter and
produce designs. This effort determines the feasibility of the Mini-Gantry concept which is a
stepping stone to publications, grants, patents, prototypes, and partnering with a proton therapy
vendor.
Contains proprietary information that B. Clasie requests not be released to persons outside the
government, except for purposes of review and evaluation._

Public health relevance
NARRATIVE The proposed project is relevant to public health because proton therapy has reduced dose to healthy tissue vs. photon therapy and hence improves health, lengthens life, and reduces illness and disability in patients receiving external beam radiation therapy. Despite the fundamental dosimetric advantage of proton therapy, there are only 44 proton therapy centers in the USA due to the larger size, larger cost, and smaller economy of scale. We will determine the feasibility of reducing the gantry size while minimizing the impact to clinical capability and not complicating the design with superconductors, eccentric rotation, or seated treatments.